Coordinating Individually Measured Phenotypes to Advance Mental Health Research

Project Summary

There is no change from the parent award.

Mental health research faces significant challenges, including the heterogeneity of diagnostic groups and the lack of precise characterization of individual patients, hindering effective clinical decision-making. However, data-driven approaches, such as machine learning and computational analyses, have emerged as crucial tools to address these challenges. By integrating data from behavioral assessments, clinical records, and biological markers, these approaches can generate more precise and objective clinical phenotypes, leading to improved diagnostic accuracy, personalized treatment selection, mechanistic insights, and enhanced monitoring and prognosis. The use of data-driven approaches holds immense importance in revolutionizing mental health research, enabling tailored interventions, and advancing our understanding and management of mental disorders. By integrating diverse data sources and leveraging advanced computational techniques, the Individually Measured Phenotypes to Advance Computational Translation in Mental Health (IMPACT-MH) initiative was formed, with the goal to harness the power of big data to address the complexity and heterogeneity of mental disorders, ultimately improving patient care and outcomes. Research gap: Mental disorders exhibit complex characteristics, making it difficult to represent, collect, and analyze heterogeneous data effectively. One major challenge is the absence of a unified representation for mental health data. While the Research Domain Criteria framework (RDoC) aims to provide a systematic framework, a formal representation using existing biomedical standards, such as ontologies, is still lacking. Developing such standards is crucial to generate computational phenotypes. Additionally, once data standards and normalization methods are established, disseminating them to researchers is essential for promoting the generation of interoperable and reusable data. Moreover, ensuring the generalizability of phenotyping algorithms beyond their original development institute and minimizing issues associated with potential errors are critical factors for enabling broad applications of such algorithms in mental health research. Addressing these challenges is pivotal for advancing computational phenotyping in mental health and facilitating its broader utilization. Method: To tackle these challenges, we will establish three cores within our three Aims:
Aim 1. Project Coordination and Data Management Core. This core will facilitate effective coordination and communication across IMPACT-MH projects. Additionally, it will build a robust data management system that encompasses the necessary infrastructure and pipelines to efficiently gather, integrate, store, and manipulate de-identified multi-modal data from multiple IMPACT-MH projects and submit them to NIH data repositories.
Aim 2. Data Standards Core. This core will work on defining comprehensive data standards by leveraging the RDoC framework and existing ontologies. It will also develop a consensus process and data harmonization methods aimed at maximizing the clinical, administrative, and scientific value of the various ascertainment and assessment practices used across the IMPACT-MH projects.
Aim 3. Data Analytics Core. This core will focus on conducting rigorous analyses on the aggregated data from the IMPACT-MH projects. It will develop methods to address potential errors associated with the datasets, algorithms, and applications used. By implementing sound analytical approaches, we aim to ensure the validity and reliability of the findings generated from the data.

Public health relevance
Project Narrative There is no change from the parent award. In this study, we will establish a robust data ecosystem for the IMPACT-MH consortium, producing data that is findable, accessible, interoperable, and reusable (FAIR). By adhering to these principles, we aim to greatly accelerate scientific discoveries in mental health research. To achieve these goals, the IMPACT-MH Data Coordination Center will establish three cores: Project Coordination and Data Management Core. Data Standards Core and Data Analytics Core. Through collaborative efforts and the utilization of advanced data management and analytics techniques, we are confident that our team will make significant contributions to the field and advance our understanding of mental health.